Intracerebroventricular cyclodextrin and AAV-mediated gene therapy forglobal CNS disease correction in feline NPC1 disease

Project Summary/Abstract
Niemann-Pick disease type C1 (NPC1 disease) is a hereditary disorder characterized by the lysosomal storage
of cholesterol and sphingolipids, and clinical signs of progressive cerebellar ataxia, dementia, vertical
supranuclear gaze palsy, dysphagia, and early death. There are no FDA-approved therapies for NPC1
disease. Repeated intracisterna magna (IC) administration of 2-hydroxypropyl-beta-cyclodextrin (HPßCD) in
cats with NPC1 disease prevented the onset of cerebellar ataxia, prevented Purkinje cell death, normalized
cerebellocortical and cerebrocortical cholesterol and gangliosides concentrations, and increased survival time.
These preclinical data advanced IC HPßCD into clinical trials where efficacy has been demonstrated.
However, HPßCD must be administered IC every two weeks for the duration of the patient’s life and results in
progressive dose-limiting ototoxicity, highlighting a clear need for less invasive and safer therapies for these
patients.
We hypothesize that optimization of IC gene therapy using an AAV9 vector to deliver NPC1 to the brain will
effectively prevent NPC1 disease-associated cerebellar ataxia and Purkinje cell pathology without repeated
lifelong injections and without ototoxicity. We also hypothesize that intracarotid (IV) administration of a novel
AAV serotype to cats can deliver NPC1 to the basal ganglia and brainstem, regions which are untreated by IC
administration of HPßCD or AAV9, and are responsible for dystonia, vertical supranuclear gaze palsy, and
dysphagia. Therefore, in the proposed studies we will assess methods to optimize AAV9-mediated
transduction of the greatest number of Purkinje cells (Aim 1), evaluate the efficacy of AAV9-NPC1
administration to treat clinical, biochemical, and histologic aspects of NPC1-associated cerebellar disease (Aim
2), and evaluate the efficacy of intracarotid AAV-NPC1 administration to treat extracerebellar regions
responsible for dementia (cerebral cortex), dystonia (basal ganglia), and vertical supranuclear gaze palsy and
dysphagia (brainstem) (Aim 3).
These proof-of-concept studies will be the first to optimize the delivery of a non-diffusible membrane-bound
protein to Purkinje cells, thereby advancing gene therapy for many other genetic diseases affecting Purkinje
cells including spinocerebellar ataxias. Moreover, these studies will be the first to develop a one-time therapy
for NPC1 disease that treats both cerebellar and extracerebellar disease and results in no ototoxicity.

Public health relevance
Project Narrative Niemann-Pick disease type C1 (NPC1 disease) is a hereditary disorder characterized by the lysosomal storage of cholesterol and sphingolipids, and clinical signs of progressive cerebellar ataxia, dementia, vertical supranuclear gaze palsy, dysphagia, and early death. Despite the identification of causative mutations and a partial understanding of the function of the lysosomal membrane-bound NPC1 protein, there are no FDA- approved therapies for NPC1 disease. This study will be the first to develop gene therapy approaches that will allow widespread correction of NPC1-associated disease in the brain of a large animal model and will provide proof of concept for advancement of this strategy to the clinics.